Caregivers-Patients Support to Latinx Coping with Advanced-Cancer

Project Summary
The goal of this K08 is to prepare the PI, to receive hands-on experience in implementation
and dissemination, designing and leading randomized controlled trials (RCTs) in palliative care,
and improve grant writing skills to become an independent R01-funded investigator.
Hispanic/Latinx (H/L) communities experience disparate general health outcomes and are more
likely to be diagnosed with advanced cancer when compared to non-H/L populations. H/L patients
experiencing advanced cancer and their caregivers are at an increased risk for unmet
psychosocial needs; this K08 will allow the PI to focus on this important gap in minority health
care. The research goal of this proposal is to refine and pilot an intervention titled: Caregivers
Patients Support to Latinx Coping with Advanced Cancer (CASA), a five-session, 60-minute each
telehealth series for patient-caregiver dyads. The long-term training goal of this application is
to enable the applicant (PI) to become an independent investigator as a cultural adaptation expert
on psychosocial interventions in health disparity research. The rationale for this project is that it
will lay the groundwork for a Randomized Control Trial (RCT) testing the efficacy of CASA. It will
also assess the implementation of an innovative method to deliver the CASA intervention. This
study aims to use the collaborative intervention planning framework and ORBIT model to modify
and assess the feasibility and preliminary effect of the CASA intervention. The overall impact of
this study is to improve access to psychosocial, culturally adapted interventions among H/L
patients and caregivers coping with advanced cancer. The Specific Aims are as follows:
Aim 1. Use a collaborative intervention planning framework with providers and community
stakeholders to refine study procedures prior to the implementation of a pilot randomized
controlled trial.
Aim 2: To train community members as patient recruiters and clinical psychology doctoral
students as interventionists of the CASA intervention.
Aim 3: To implement a pilot randomized controlled trial to evaluate the feasibility, acceptability,
and potential efficacy of the CASA intervention with Hispanic/Latinx dyads coping with cancer.

Public health relevance
Project Narrative The goal of this K08 is to prepare the PI (Normarie Torres-Blasco, Ph.D.) to become an independent investigator to address health equity through access to culturally adapted interventions for Hispanic/Latinx patients-caregivers coping with advanced cancer. The research goal of this proposal is to refine and pilot an intervention titled: Caregivers-Patients Support to Latinx Coping with Advanced-Cancer (CASA), five 60-minute telehealth sessions for patient- caregiver dyads. This study aims to use a collaborative intervention planning framework that blends community-based participatory research and dissemination and implementation models to modify and assess the feasibility and acceptability of the CASA intervention.